VET-LIRN Network capacity building projects..

PROJECT SUMMARY
Instructions:
The summary is limited to 250 words. The names and affiliated organizations of all Project Directors/Principal Investigators (PD/PI) should be listed in
addition to the title of the project. The summary should be a self-contained, specific description of the activity to be undertaken and should focus on: overall
project goal(s) and supporting objectives; plans to accomplish project goal(s); and relevance of the project to the goals of the program. The importance of a
concise, informative Project Summary cannot be overemphasized.
Title: Vet-LIRN Network Capacity-Building Projects
PD: Tewari, Deepanker Institution: Pennsylvania Department of Agriculture
Pennsylvania Veterinary Laboratory
CO-PD Institution:
CO-PD: PD/PI 3 Name (Last, First, MI) Institution:
CO-PD: PD/PI 4 Name (Last, First, MI) Institution:
CO-PD: PD/PI 5 Name (Last, First, MI) Institution:
CO-PD: PD/PI 6 Name (Last, First, MI) Institution:
CO-PD: PD/PI 7 Name (Last, First, MI) Institution:
Project will help with the following objectives
1. Increasing the capacity of laboratories conducting pathogen susceptibility testing
by funding the updating or purchasing of additional equipment.
2. Procurement of supplies needed for WGS testing efforts or method improvement.
This file MUST be converted to PDF prior to attachment in the electronic application package.

Public health relevance
Project narrative 1. Increasing the capacity of laboratories conducting pathogen susceptibility testing by funding the updating or purchasing of additional equipment. Pennsylvania Veterinary Laboratory will participate in pathogen susceptibility testing as per the requirement of the program. Funds are needed for purchase of media, reagents and consumables used in pathogen susceptibility testing and offer services for case investigation. 2. Procurement of supplies needed for NGS testing efforts or method improvement. Laboratory is expanding Next Generation Sequencing using Illumina MiSeq platform. Support for reagents and consumables will help with validation and testing of the platform for investigations related to LIRN